Diabetes Mellitus and Disorders of Metabolism

PROJECT SUMMARY/ABSTRACT
This proposal seeks continued support for the Yale research training program in Diabetes Mellitus and
Disorders of Metabolism. This program remains the core of support for postdoctoral research training in
diabetes and metabolic diseases at the Yale School of Medicine. We strive to provide physicians and
scientists with the training required to pursue academic careers in clinical, translational and basic research.
Physician trainees entering the program will have MD or MD, PhD degress and at least 2-3 years of clinical
training in internal medicine or pediatrics. Post-doctoral PhD scientist are also recruited into the program since
we believe an integrated training experience bringing together adult endocrinologists, pediatric
endocrinologists and endocrine scientists will prepare our trainees to participate in modern multidisciplinary
research groups. We also now propose to introduce pre-doctoral PhD and MD, PhD students selected from
the Yale Graduate School and MSTP programs who will enter the new Yale graduate BBS Program in
Translational Biomedicine (PTB). All trainees will be selected based on their aptitude and commitment to
research careers in diabetes and/or metabolism. Post-doctoral training will encompass at least three years to
ensure an in-depth training experience leading to an independent research career. Pre-doctoral training is
anticipated to cover years 3 and 4 of the PhD degree. The cornerstone of both curricula is participation in a
specific research project under the supervision of a designated preceptor and guided by a progress committee
or thesis committee composed of 2-3 other members of the training faculty. Potential projects run the gamut
from clinical to basic research in 3 primary areas of emphasis: 1) T1D, 2) T2D, and 3) bone and mineral
metabolism. Trainees have the opportunity to work with mentors in multiple basic science departments as well
as those in Pediatrics and Medicine. Close interactions among preceptors and trainees within each
programmatic area are enhanced by the interdepartmental Diabetes Research Center adminstered within the
Endocrine Section. In this cycle, we have also recruited members of the new basic science focused Yale
Center for Molecular and System Metabolism to further enrich research opportunites. Instruction is also
provided through organized lectures, research seminars and journal clubs. The application requests a reduced
allotment of 5 post-doctoral stipends per year as well as 2 new pre-doctoral slots to support graduate student
education in the PTB. This request is based on our longstanding and outstanding track record of training
successful investigators who remain in academic research careers, our ongoing ability to attract outstanding
applicants, the high level of research productivity of our training faculty, the expansive palette of research
opportunities provided by our faculty and the continued shortage of physician-scientists and scientists that are
dedicated to research careers in diabetes and metabolic diseases.

Public health relevance
PROJECT NARRATIVE Obesity, diabetes and osteoporosis are increaingly prevalent metabolic diseases that are reponsible for a great burden of suffering and death as well as large healthcare expenditures in the US and throughout the world. Academic endocrine researchers are needed to better understand these diseases and to translate research findings into new and improved therapies. The Yale T32 program in Diabetes and Disorders of Metabolism is dedicated to providing young graduate students, physicians and scientists with the research training necessary to tackle these important public health problems.